METABOLIC IMPACTS OF TYPE II INTERFERON SIGNALS IN OBESITY

ABSTRACT
Obesity coincides with pro-inflammatory phenotypes in adipose tissues and the insulin resistance that precedes
type 2 diabetes. Despite a wealth of evidence, causal relationships between obesity-induced inflammation and
insulin resistance remain unknown. In the last grant cycle, we explored how inflammation uncouples obesity
from insulin resistance. We showed blocking interferon gamma (IFNg) activation of the transcription factor STAT1
limits pro-inflammatory programs that would otherwise restrict white adipose tissue (WAT) expansion and
decrease insulin sensitivity. We also demonstrated complete elimination of IFNg activity mediates many adverse
effects of high fat diet, including weight gain, diminished mitochondrial function, and insulin resistance. Multiple
studies, including our own, observed higher STAT1 expression in WAT of diabetic mice and humans, suggesting
that IFNg activity may still represent a pathogenic consequence of chronic obesity. The goal of the current cycle
is to fill vital remaining gaps in our mechanistic understanding of the fundamental ways IFNg transmits signals to
transcriptional regulation of metabolism and insulin sensitivity in fat cells. To achieve our goal, we will
demonstrate that the IFNg receptor in WAT initiates the metabolic decrement of overnutrition (Aim 1) and
establish the downstream transcriptional outcomes of IFNg that repress cellular energy balance in the fat cell
(Aim 2). Lastly, we will determine whether obesity-associated inflammation restricts a novel pathway that
supports lipogenic responses necessary to sustain WAT expansion (Aim 3). Ultimately, such knowledge will
teach us how to leverage the immune system to treat obesity and its co-morbidities.

Public health relevance
NARRATIVE Obesity is an inflammatory condition that remains a universal contributor to type 2 diabetes. During the last grant award cycle, we defined pathways that temper the effects of inflammation on insulin sensitivity in obesity. After the next five years, we will know why certain inflammatory signals couple obesity with type 2 diabetes.